Cancer Center Administration

Abstract: Cancer Center Administration
The UPMC Hillman Cancer Center (HCC) Administrative Core (Admin Core) provides infrastructure to facilitate
and stimulate the cancer research, education, and outreach activities of 280 HCC faculty members in 7
research programs, with particular focus on research that is transdisciplinary and translational. It also supports
the HCC Director, Senior Leaders, Program Leaders, Shared Resources Directors, and internal and external
advisors, through effective strategic planning and evaluation, operational management, and centralized data
resources.
The Admin Core supports the matrix Cancer Center by overseeing one of the largest research units ($115M
overall budget in FY2020) at the University of Pittsburgh (Pitt). It provides grant and fiscal management and
other administrative services for 128 HCC faculty in center-controlled space and 10 state-of-the-art Shared
Resources, many residing in 530,795 ft2 of HCC-controlled space that is also managed by administrative staff.
The Admin Core is responsible for: performing human resource functions and administering partial salary
support for >1,200 FTEs; managing the Cancer Center’s finances, personnel, grants and contracts,
purchasing, and philanthropy; providing administrative and financial oversight to HCC’s shared resources;
overseeing space utilization and common equipment; facilitating faculty recruitment efforts; managing Cancer
Center membership; facilitating pilot award programs; and coordinating planning and evaluation activities that
include faculty surveys, leadership and programmatic meetings, seminars, annual retreat, and internal and
External Advisory Board meetings. The Admin Core also supports communication to HCC faculty members
and the larger Pitt community through newsletters, publications, and a website; and educates residents of our
29-county western Pennsylvania catchment area and lawmakers regarding HCC activities and other cancer-
related issues, through outreach efforts. The Admin Core monitors and reports member accomplishments,
funding, and other cancer-related activities to the Senior Leadership Team as a part of an annual membership
evaluation, and for reporting HCC progress to the National Cancer Institute.
Admin Core accomplishments during 2015-2019 included: significantly contributing to HCC research program
restructuring; developing new Microbiome and Population Survey shared resources and a formal pilot grant
program; recruiting and onboarding over 40 new faculty members; and facilitating submission of several large
team science multi-component grants. For CCSG year 32, the Center requests $146,605 to support partial
salary for 10 FTEs plus costs for supplies, travel, and other operational expenses. The Admin Core represents
3.5% of the total CCSG budget request and 2.2% of the overall HCC Administration annual operating budget
($6.6M).